Advancing Quality and Outcomes Measurement in Rheumatology

Project Summary
Healthcare has changed rapidly in the last decade with the widespread use of electronic health records (EHRs)
and the creation of national EHR-based data networks that aim to improve the quality of care. The American
College of Rheumatology’s RISE registry is a federally Qualified Clinical Data Registry that collects EHR data
from the practices of almost 1000 rheumatologists nationally, analyzes these data centrally, and continuously
feeds back performance on quality measures to practices via a web-based dashboard. In this K24 proposal,
the applicant seeks to leverage this infrastructure to improve care for individuals living with lupus, a population
that has historically faced significant health disparities and gaps in quality of care. The proposed research will
validate newly developed lupus quality measures across RISE practices (Aim 1). In addition, using an
implementation science theory framework and qualitative methods, the applicant will create a toolkit to facilitate
meaningful use of lupus patient-reported outcome measures (PROMs) in clinical practice (Aim 2). These
studies will develop a rigorous scientific framework for measuring and improving the quality of care and
outcomes for individuals with lupus across the United States. The proposed projects will draw on the
candidate’s strong research portfolio, funded by the Centers for Disease Control and Prevention, the Agency
for Healthcare Research and Quality, and the National Institutes of Health, as well as the outstanding
institutional environment at the University of California, San Francisco (UCSF). For this five-year K24 award
renewal, the applicant seeks to maintain her record of successfully mentoring trainees interested in patient-
oriented clinical research in rheumatology, both at UCSF and at other institutions. The newly proposed studies
as well as the data available from other funded studies provide rich resources for trainees who are interested in
patient-oriented clinical research in rheumatology related to the use of registries, EHR data, PROs, quality
measurement and implementation science.

Public health relevance
Project Narrative This mid-career investigator award will support a program in patient-oriented research in rheumatic diseases at the University of California, San Francisco. The award will allow the applicant to expand her research on the development and validation of health care quality measures and will support her mentoring of early investigators. The proposed research aims to develop tools that will facilitate measuring and improving the quality of care for lupus, a condition where gaps in quality of care and health disparities are well-documented.